RNA trafficking in mitochondria

SUMMARY
Mitochondria have numerous signaling pathways for conveying stress to the rest of a cell. Similar to
pathogens that release pathogen-associated molecular patterns (PAMPs), mitochondria release novel
damage-associated molecular patterns (DAMPs), including lipids, peptides, and mitochondrial DNA (mtDNA),
that indicate mitochondrial stress. Mitochondrial double-stranded RNA (mtdsRNA) is a new class of DAMPs
that is generated when the noncoding strand in mtRNA is not degraded efficiently and accumulates, allowing
base-pairing with the coding strand. Under normal conditions, the helicase SUV3 unwinds the mtRNAs and
polynucleotide phosphorylase (PNPase)ndegrades them. However, knockdown of SUV3 results in the
accumulation of mtdsRNAs within mitochondria, and knockdown of PNPase leads to the release of the
mtdsRNAs into the cytosol. Once in the cytosol, the mtdsRNAs are sensed by dsRNA sensors MDA5 and
RIG-I, leading to the induction of the type I interferon pathway. The export of mtdsRNA is likely important as
mtdsRNAs have been identified in the cytosol of patients with mutations in PNPT1, encoding PNPase, and in
diseases including cancer, cardiac disease, alcohol-associated liver disease, and autoimmune diseases.
The hypothesis that mtdsRNAs represent a new biomarker for mitochondrial dysfunction will be tested.
As this is a new pathway, there is a critical gap in understanding the molecular rules and mechanisms by which
mtdsRNAs cross the mitochondrial inner and outer membranes for cytosolic export. Our study goals are
contained within three independent, but thematically connected, specific aims. In Aim 1, mtdsRNAs that are
exported from mitochondria will be characterized with respect to size and sequence specificity. In addition,
RNA modifying enzymes will be tested to determine which components are essential for the generation of
mtdsRNAs. Aim 2 will focus on identification of outer and inner membrane channels and the role of PNPase in
the trafficking of mtdsRNAs out of mitochondria. The third aim will define physiologic parameters that lead to
the generation of mtdsRNAs and determination of the cytosolic dsRNA sensors that become activated during
this process. Because mutations in PNPase lead to mitochondrial disease, mutants will be characterized to
determine whether steps in the degradation and/or export of mtdsRNAs can be separated.
Our study team has been characterizing PNPase and its function in mitochondria extensively. Unique
model systems available for our work include a mouse model in which floxxed PNPT1 can be removed by the
Cre recombinase, and mouse embryonic fibroblasts derived from this model. Results from this proposal will
define the pathway for mtdsRNA trafficking out of mitochondria in detail and provide a platform for
understanding how mutations in PNPase contribute to disease. Long-term, these studies may lead to
establishing mtdsRNA as a new biomarker for mitochondrial dysfunction.

Public health relevance
PROJECT NARRATIVE This proposal will provide fundamental new knowledge on the mechanisms and rules for exporting mitochondrial DNA-encoded double-stranded RNAs into the cytosol of mammalian cells. This process and pathway becomes activated during times of mitochondrial stress and induces a robust immune response, thereby resembling an infection by a double-stranded RNA virus coming from outside of a cell. Mutations in the central component of this process and pathway, PNPase (polynucleotide phosphorylase), have been identified in inherited deafness and in neurodegenerative diseases, highlighting the importance of this export pathway in human health and disease.